Immunotherapeutics to prevent HCV reinfection

DESCRIPTION (provided by applicant): Up to 170 million people worldwide are chronically infected with HCV Hepatitis C virus (HCV) putting the infected individuals at significant risk for cirrhosis, liver failure and liver cancer. End- stage liver disease caused by HCV is the leading indication of liver transplantation (LT) in the United States. However, reinfection with HCV occurs universally and allograft failure because of reinfection is the most common cause for retransplantation and death among HCV-infected LT recipients. Shortly after LT, HCV reinfection is universal and poorly controlled by current antiviral treatments. While there is new optimism in the treatment of chronic HCV infection with two recent FDA approved direct acting antivirals DAA, telaprevir and boceprevir, they are not recommended for treating HCV in the transplant setting due to likely adverse drug-drug interaction. Cumulative evidence indicates a protective role for virus neutralizing (Vn) antibodies for HCV, which could be used as an alternative approach to prevent HCV reinfection in liver transplant recipients. The goal of this project is to develop a highly effective immunotherapeutic to prevent HCV reinfection in liver transplant patients based on antibodies that limit the ability of the virus to escape via mutations In Specific Aim 1, broadly neutralizing human monoclonal antibodies (HMAb) to HCV envelope glycoprotein will be produced via affinity maturation that are not associated with viral escape. A yeast display system will be used to affinity mature HMAbs for improved binding and neutralization authentic cell culture infectious HCV virion (HCVcc) of different genotypes. The lead antibodies will be assessed for the ability to limit viral escape with multiple infectious HCVcc. The antibody with the highest potencies and an acceptable stability profile against different HCVcc genotypes along with its wt clone will be selected for testing using the uPA/SCID model. In Specific Aim 2, the affinity matured HCV HMAb having greatest neutralizing potencies against diverse genotype HCVcc, and not associated with viral escape, will be evaluated in the uPA/SCID chimeric human liver mouse model of acute HCV infection. Subsequent and future work will further evaluate the lead candidate(s) leading to a final candidate product, conduct the crucial, additional efficacy studies in a HCV human-mouse liver chimeric animal model, establish the required assays for clinical development, and develop the required cell banks and a scalable manufacturing process for production of a clinical lot for testing in a phase 1 safety and immunogenicity human clinical trial.

Public health relevance
Up to 170 million people worldwide are chronically infected with HCV Hepatitis C virus (HCV) putting the infected individuals at significant risk for cirrhosis liver failure and liver cancer. End- stage liver disease caused by HCV is the leading indication of liver transplantation in the United States. However, reinfection with HCV occurs universally and allograft failure because of reinfection is the most common cause for retransplantation and death among HCV-infected LT recipients. The goal of this project is to develop a highly effective immunotherapeutic to prevent HCV reinfection in liver transplant patients based on antibodies that limit the ability of the virus to escape via mutations.